DEVELOPMENT OF RECOMMENDATIONS FOR CODING ACROSS CANCER REPORTING SYSTEMS FOR SEER

The purpose of this contract is to support activities of the National Cancer Institute’s Surveillance, Epidemiology and End Results (SEER) Program. Specific areas of activities and technical expertise relate to national and international Cancer Staging and Coding Systems.